The Powers of Heaven and Earth: The Concept of Dunamis from the Ancient Mediterranean to the Early Modern Atlantic World

Project Summary/Abstract
This project investigates the long history of the concept of dunamis in the Western intellectual tradition
from its earliest emergence as a technical term in Hippocratic medicine to denote the ontology of
substances, and to do so with a focus on plants. Translated as faculty, potentiality, or power, dunamis
(δύναμης) signified the innate power in substances that directed them to develop and function in a
particular way, according to their fundamental nature. The concept continued to play an important role
through the Arabic and Latin Middle Ages and well into the early modern period, underlying a wide range
of causal explanations in medicine, natural philosophy, theology, and psychology. Despite its
fundamental and longstanding place in the Western tradition, however, dunamis has yet to be properly
understood in its development and use over time. In general, scholars have not traced its meaning beyond
their field or era of specialization, and inconsistency in the translation of dunamis from the original Greek
to Arabic and especially to Latin have further hindered recognition – but at the same time provide
evidence of its varied and widespread presence in these intellectual traditions.
The project first delves into ancient understanding of dunamis in the nature and substance of plant
materials, then examines the medieval Arabic and Latin investigation of dunamis in plants through the
practice of alchemy and astrology in the Abbasid Empire (750-1258CE) and the Latin West, as these were
fields that sought to understand the different powers in plant substances and their heavenly
influences. Finally, the project examines how these ideas impacted agricultural practices in medieval Al-
Andalus (Islamic Spain, 711-1492CE) and traces that impact on the Americas under the Spanish Empire
(1493-1898). Thus, despite its focus on the history of an idea, this project is not solely an intellectual
history. Rather, its examination of dunamis in plants allows for a two-pronged approach to the topic and
the source material. It will investigate not only the philosophical foundations and import of the concept,
but also its practical applications and impact on plant cultivation. Primary sources for data collection will
include treatises in medicine and natural philosophy as well as practical works such as farming manuals,
herbals, formularies, and almanacs. The specific aim of the project is to produce a monograph of six
chapters that will be submitted to a university press for review and publication. The monograph will not
only highlight the importance of dunamis over the longue durée, but in doing so will challenge existing
norms and paradigms of scholarship in the history of science and medicine by encouraging
interdisciplinarity, disrupting traditional binaries – of modern versus “primitive,” science versus
medicine, East versus West – and thus fostering inclusivity.

Public health relevance
Project Narrative This project on the history of the concept of dunamis demonstrates the importance and relevance of historical continuity through periods of intellectual upheaval such as the Renaissance, the Scientific Revolution, and the Enlightenment, which are often equated with the emergence of modernity, paving the way for modern Western medicine and modern ideas regarding best practices for promoting the health of the public. Dunamis signified the innate power of substances to develop and function according to their intrinsic nature or purpose – their ontology – and in this way constituted a fundamental and relatively stable way of understanding the causes and behaviors of matter throughout these eras. As such, it shaped investigation and understanding of health, disease, and treatment over two millennia in Greek, Arabic, Latin, and vernacular traditions, thus showing not only the importance of the past in understanding the path to modernity, but also its varied origins.